Title: Determination of LMP744 (NSC 706744) Levels in Human Plasma and Urine Samples from an NCI Phase I Trial.POP: 04/10/2017 - 04/09/2018

A series of indenoisoquinoline inhibitors of topoisomerase I have been extensively studied by the NCI, and two of these compounds (LMP400 and LMP 776) have previously been investigated in human clinical trials.